Alcohol treatment in Medicaid managed care plans: Disparities in policies and outcomes

Rates of alcohol-related morbidity and mortality are disproportionately high and increasing among racial/ethnic
minorities and women and in rural areas. Almost 90,000 Americans die annually from alcohol use. Despite the
health consequences, fewer than 10% of those with alcohol use disorder (AUD) receive evidence-based
treatment, and racial/ethnic minorities and women are less likely to access treatment. Barriers to treatment
include stigma, treatment setting appeal, and health insurance benefit design. Medicaid programs are among
the most important payers for AUD treatment and rates of AUD in the Medicaid population are especially high.
Medicaid provides health insurance for more than 77 million Americans, including a large and disproportionate
share of racial/ethnic minorities, women, and rural Americans. Almost all state Medicaid programs contract with
Medicaid managed care organizations (MMCOs) to deliver and manage health care services and nearly 70%
of Medicaid enrollees are now in managed care. MMCOs must adhere to state requirements and policies, but
have considerable discretion over polices that may influence access, treatment appeal, and cost. However,
there is almost no information or transparency on MMCO polices related to alcohol treatment services. This
study systematically examines AUD treatment policies in MMCOs, an under-explored level where important
decisions are made that influence access and outcomes. We will conduct a national survey of MMCOs and link
their responses to patient-level Medicaid data. The specific aims are: 1) Examine Medicaid MMCO alcohol
treatment policies (e.g. coverage, utilization management, provider networks, innovations) across MMCOs that
contract with the 50 states and District of Columbia; determine whether there are differences in MMCO alcohol
treatment policies by state Medicaid policies. 2) Assess the relationship between MMCO policies and access to
AUD treatment (e.g. initiation and engagement in treatment, follow-up after hospitalization) by race/ethnicity,
gender, and rural/urban geography. 3) Assess the relationship between MMCO policies and alcohol treatment
outcomes (i.e.. treatment retention, pharmacotherapy duration, hospitalization, ED visit) by race/ethnicity,
gender and rural/urban geography. Our interdisciplinary team is uniquely qualified with experience conducting
four previous commercial health plan behavioral health studies, and conducting rigorous disparities and
Medicaid analyses. Findings will provide valuable information on MMCO policies and their associations with
access, treatment appeal and cost for racial/ethnic minorities and other Americans. This information can be
used by plan administrators as they develop and implement policies, state Medicaid directors as they contract
with and regulate MMCOs, and federal policy makers making determinations about Medicaid waivers and other
efforts to improve access to alcohol treatment in the US.

Public health relevance
This study will examine Medicaid health plan policies related to delivery and management of alcohol use disorder treatment and their relationship with access to and outcomes of care for racial/ethnic minorities, women and rural Americans. Findings from this study will help health plan administrators as they develop and implement plan policies, state Medicaid directors as they contract with health plans, and federal policy makers making decisions about Medicaid policy, to help improve access to alcohol treatment.